A comprehensive platform for low-cost screening and image-guided photodynamic therapy (PDT) of pre-malignant and malignant oral lesions in low resource settings

Project Summary
The recently awarded U01 project entitled “A comprehensive platform for low-cost screening and image-guided
photodynamic therapy (PDT) of pre-malignant and malignant oral lesions in low resource settings” (U01
CA279862) seeks a diversity supplement to promote the career development of undergraduate student Sergio
Farias. Mr. Farias works under the mentorship of Dr. Jonathan P. Celli, at UMass Boston. This supplement will
enable him to investigate photobleaching as a quantitative and real-time reporter of photodynamic therapy
(PDT) dose response. As noted in Specific Aim 2 of the competing proposal, the capability of the screen,
image and treat optical system (SITOS), the core technology of this U01 proposal, is significant for its potential
to provide a contemporaneous reporter of PDT dose deposited in tissue. Through this supplement Mr. Farias
would investigate this systematically using tissue phantoms and 3D cell culture models as a platform to study
real-time changes in photosensitizer fluorescence correlated with acute response and tumor regrowth. At the
same time Mr. Farias will benefit from intensive mentorship and direct hands-on experience in cutting edge
cancer research that will help him stand out in applications to competitive biomedical research graduate
programs. Outside the lab he will continue to pursue his coursework, scientific and professional development
seminars, and journal clubs.

Public health relevance
Narrative A new platform is envisioned that combines two existing technologies to produce a low cost, simple to use, handheld device that can screen patients for high-risk oral cancer, image the location of the cancer, and treat it using this same device at point of care. It includes testing therapeutic efficacy both pre-clinically and clinically in patients, along with identification of an easy-to-use topical application of the therapeutic agent well suited for low-income settings. The impact of these studies could be substantial in the low-income settings such as rural areas and can avoid deaths in the regions where oral cancer is highly prevalent in India as well as other countries including regions of the U.S.A.